Gastric Endocrine Functions in Skeletal Homeostasis

Bariatric surgery-associated skeletal complications have been observed since the early 1990s, and are
associated with increased fracture risk. The most prevalent bariatric surgery is vertical sleeve gastrectomy
(VSG), which removes most of the stomach. By 12 months after surgery, bone loss of 4–8% in the hip and 3–
10% in the femoral neck increases fracture risk 1.3 to 2.3-fold. Current clinical management includes bone
mineral density assessments, consumption of adequate dietary calcium, vitamin D, and protein, and weight-
bearing exercise. These countermeasures minimize, but do not fully prevent bone loss secondary to bariatric
surgery. A clearer mechanistic understanding of bone loss associated with bariatric surgery is necessary to
properly design preventive strategies. Changes in gut hormones and microbiota have been proposed to drive
bone loss, but the effects of loss of the stomach have been largely neglected. We propose that gastric
secretory factors contribute to bariatric surgery-induced skeletal complications. In key preliminary data, we
found a loss of gastric X/A-like cells (P/D1 cell in humans) and a decrease in secreted ghrelin following VSG.
Genetic ablation of X/A-like cells was found to improve glucose metabolism and impair trabecular bone mass,
which mimics the metabolic and skeletal consequences of VSG. However, ghrelin supplementation alone does
not prevent VSG-induced bone loss. Our proteomic profiling identified ghrelin and somatostatin as the top two
secretory proteins enriched in X/A-like cells and decreased by VSG. Moreover, circulating exosome
concentrations and gastric RAB27A, a Rab GTPase critical for extracellular vesicle (EV) secretion, were
significantly upregulated by VSG. These data suggest that X/A-like cells are a source of secretory factors vital
to bone homeostasis, and bariatric surgery disrupts this balance. The specific aims of this proposal are: 1) to
define the skeletal and metabolic consequences of gastric X/A-like cell ablation and identify X/A-like cell-
derived secretory factors that affect skeletal homeostasis; and 2) to determine the effects of gastric X/A-like
cell-derived hormonal factors and EV cargoes on VSG-induced bone loss. In aim 1, we will utilize the X/A-like
cell ablation mouse model to determine the importance of these cells in skeletal health under conditions of
metabolic stress, including diet-induced obesity and estrogen deficiency. Furthermore, we will identify
secretory factors from X/A-like cells and determine their roles in osteoblast, osteoclast and adipocyte
differentiation and function. In aim 2, we will test whether somatostatin can enhance the pro-osteogenic effects
of ghrelin and protect against VSG-induced bone complications. In addition, we will delete Rab27a in X/A-like
cells to determine its pathophysiological functions in bone, glucose and lipid metabolism under lean healthy,
obese and VSG conditions. Understanding the significance of X/A-like cells in bone metabolism holds promise
for developing new therapeutic targets to manage bariatric surgery-induced bone loss, which remains one of
the few time-tested options for improving health of severely obese individuals.

Public health relevance
Project Narrative Bariatric surgery leads to durable weight loss, enhances quality of life and improves metabolic health; however, bone loss is a side effect. This project uses innovative genetic mouse models to define novel molecular signaling pathways between the gut and the bone that impact skeletal health, targeting endocrine cells in the stomach. This work will define novel functions of gastric endocrine cells and broadly apply to metabolic bone disorders and osteoporosis.